Genetic factors controlling the intensity of social behavior

Project Summary
The goal of this equipment supplement for the parental award (R35GM119844) is to expand the capability of
multiphoton imaging microscopy in the Asahina lab so that neural activities in the brain of a live fly can be
monitored while the experimenter applies complex sensory stimuli and pharmacological reagents,
optogenetically and thermogenetically manipulates specific neuronal population, and records behavior. To
achieve the goals outlined in the parental grant, it is increasingly necessary to understand physiological
dynamics of aggression-controlling circuits. To calculate relative cost and benefit of a given social behavior in a
context-dependent manner, the fly brain must amplify or diminish relevant sensory information according to the
animal’s nutritional and hormonal conditions, as well as the individual behavioral history unique to each
individual. The functional imaging setup currently available in the recipient’s lab is inadequate to quantitatively
detect context-dependent representation of sensory cues, because the outdated design of the microscopy
constrains the space available near the objective lens. The proposed piece of equipment for purchase is a
gantry frame with a motorized XY-stage. The simplified support structure of the frame will eliminate
unnecessary space-filling parts of the microscopy that surround the objective lens, while the stage provides a
mounting space sufficient for setting up multiple stimulus-delivery setups, LED, heat probe, and other devices
for neuronal manipulations. These features will greatly facilitate the successful completion of the goals of the
parental grant.

Public health relevance
Project Narrative Neural activities under complex sensory and pharmacological conditions in the brain of a behaving animal contains unparalleled amount of information that helps elucidate the functional principles of neural circuit. This equipment supplement will allow the recipient of the parental award to expand its capacity to monitor neural activities under a variety of sensory stimuli and artificial neuronal manipulations, which will be critical for understanding how the nervous system integrates information about cost and benefits when choosing a proper action during social interactions.